Drivers of adaptation and colonization within individual human microbiomes

LOCAL AND GLOBAL SELECTIVE FORCE WITHIN MICROBIOMES
The human microbiome harbors a large capacity for within-person adaptive mutations. Commensal
bacterial strains can stably colonize a person for decades, and during this time billions of bacterial
mutations are generated daily. Adaptive mutations emerging during colonization might be driven by
selective forces that are new to urban industrialized societies, vary across individuals, or vary across times
within an individual. These changes could alter the impact of strains on the immune system, the metabolism
of particular nutrients or drugs, and the stability of the microbiome to invasions or perturbations.
Despite this potential, still little is known about the extent of evolution within human microbiomes or its
interplay with ecological forces. This knowledge gap emerges from limitations of traditional approaches;
metagenomics does not provide the resolution needed to accurately identify de novo mutations, and model
animal microbiomes have relatively limited potential for adaptation due to their shorter lifespans, smaller
microbial population sizes, and constrained environmental complexity. To overcome these limitations, my
lab studies in vivo evolution using high-throughput culture-dependent methods. Using this approach to we
have discovered evidence that, even in the absence of antibiotic treatment, adaptive de novo mutations
reach high frequency within healthy people. However, it is unknown if such adaptation is common across
species or capable of spreading person-to-person.
This proposal outlines a long-term strategy to develop the intuition, rules, and exceptions regarding ongoing
adaptation and selective forces within human microbiomes. First, we will use a culture-dependent genomic
approach to characterize within-person evolution over a dozen species in human microbiomes, including
residents of the skin, vagina, and large intestine. We will characterize niche traits that predict the balance of
neutral and adaptive forces across species, as well as elucidate the role of person-specific selective forces in
evolution and initial engraftment of migrating strains. Second, we will characterize across-person evolution
using PHLAME, a computational platform for phylogenomics we developed that leverages rapidly accruing
public metagenomic data. We will identify bacterial strains with recent success within and across human
environments. We expect to uncover principles underlying adaptive evolution of commensals within and
across humans and to lay the groundwork for a microbiome framework that integrates both evolutionary
and ecological forces, which will pave the way towards more successful microbiome-targeted therapies.

Public health relevance
Project Narrative Human microbiomes vary between people in terms of their species composition, strain composition, and the mutations occurring within individual strains. This research will characterize the extent and drivers of person-specific and global selective forces in driving these differences. The principles we uncover will guide future research into the role of microbiome mutations in health and disease and assess the need for personalization in the design of microbiome therapies.